Elucidating the Role of the Tumor Suppressor KEAP1 in Antitumor Immunity

Project Summary - Elucidating the role of the tumor suppressor KEAP1 in antitumor immunity
Lung cancer is the leading cause of cancer-related deaths worldwide, with non-small cell lung cancer (NSCLC)
being the most common subtype, representing approximately 85% of all diagnoses. Among the major drivers of
lung cancer, about 20% of NSCLC patients exhibit loss-of-function mutations in the tumor suppressor and E3
ubiquitin ligase KEAP1. Although immune checkpoint blockade (ICB) inhibitors represent the most recent
breakthrough in treating advanced NSCLC, a significant portion of patients experiences primary resistance,
especially those harboring KEAP1 mutations. Our recent work describes how the loss of KEAP1 leads to the
suppression of the type I interferon response, promoting lung cancer immune evasion (Marzio et al., Cell 2022).
Through multi-omic profiling of NSCLC human and mouse samples, we confirmed that KEAP1-mutant NSCLCs
exhibit immune-evasive features, including reduced T cell infiltration and resistance to immune checkpoint
inhibitors. This analysis also identified a set of novel potential KEAP1 substrates that are overexpressed in
KEAP1-mutant tumors. Among these substrates, we identified several oncoproteins that play a crucial role in the
activation of the pro-inflammatory transcription factor NF-B. The goal of the proposed research is to investigate
the hypothesis that the newly identified upregulated oncoproteins are bona fide KEAP1 substrates. We will
employ biochemistry, molecular/cell biology, and somatic cell genetic approaches to functionally and
mechanistically interrogate the contribution of these putative novel substrates in the immune-evasive phenotype
observed in KEAP1-mutant NSCLCs (Aim 1). A natural corollary of this goal is to test the premise that therapeutic
targeting of the validated substrate can improve the efficacy of immunotherapy for NSCLC (Aim 2).
Understanding how the loss of KEAP1, along with the concomitant accumulation of its substrates, promotes
immune evasion in cancer has the potential to profoundly impact our comprehension of the immune response to
NSCLC and enhance the success of therapy for this tumor type. Additionally, since KEAP1 loss-of-function
mutations are recurrent features in several malignancies, the significance of this proposal is evident. We
anticipate that our results will present a promising opportunity to treat patients with KEAP1 alterations using
novel and alternative therapeutic approaches. Completion of this work will also unveil the molecular mechanisms
underlying the physiological role of KEAP1 in regulating inflammation and immunological responses during
cancer development and progression, offering therapeutic opportunities for a substantial number of patients
whose tumors are driven by its loss. Shaped by our longstanding dedication to the field of DNA damage response
and cancer biology, this project is part of our ongoing efforts to uncover novel molecular mechanisms that
contribute to malignant transformation.

Public health relevance
PROJECT NARRATIVE/RELEVANCE Among the major lung cancer drivers, about 20% of non-small lung cancer (NSCLC) patients exhibit loss-of-function mutations in the tumor suppressor and E3 ubiquitin ligase KEAP1. Although immune checkpoint blockade (ICB) inhibitors represent the most recent breakthrough in treating advanced NSCLC, a significant portion of patients experiences primary resistance, especially those harboring KEAP1 mutations. Understanding how the loss of KEAP1 promotes cancer immune evasion has the potential to profoundly impact our comprehension of the immune response to NSCLC and enhance the success of therapy for this tumor type.